Study of the dynamics of higher order protein DNA complexes involved in variety of DNA transactions

Dynamic aspects of the chromosomes that are the target of transposing viruses such as bacteriophage Mu and HIV are studied in this project. A pair of DNA cleavages and strand transfers involving the ends of Mu or HIV DNA sequence and their interaction with chromosomal target DNA sites take place within a context of higher order protein-DNA assemblies for each DNA segments involved. The transposing viral DNA ends are assembled into higher order protein-DNA complexes called transpososome (for Mu) or preintegration complex (for HIV), the core of which is composed of two end segments of the transposing viral DNA synapsed by a tetramer or higher-order oligomers of MuA transposase or HIV IN protein. The assembly of these higher order protein-DNA complexes in nature takes place in the presence of additional DNA binding proteins that influence the assembly process. The target DNA for transposition also exists as higher order protein-DNA complexes in the form of eukaryotic chromosomes or bacterial nucleoid. How the transposing viral DNA complex assembly process and the activity of the chromosomal DNA as the target of transposition are influenced by general chromosome/nucleoid associated proteins, which impact the dynamic behavior of DNA is not well understood. In both prokaryotes and eukaryotes, chromosomal DNA molecules are kept in dynamic condensed states involving large variety of DNA condensation proteins. These proteins either bend/flex DNA, or cross-bridge distant DNA segments through direct, or indirect DNA binding. In our separate project (DK036165), we also study the mechanism of bacterial chromosome/plasmid partition systems that involve the ParA/B/S class of system components. ParA and ParB proteins also cause DNA condensation in controlled fashion, and their functional dynamics most likely are impacted by other DNA condensation proteins associated with bacterial nucleoid, NAPs (nucleoid associated proteins).

Most recently, we focused our effort to understand the mechanism of CTP-dependent F-plasmid partition complex condensation by the centromere-binding protein, ParB of F-plasmid. For more than two decades, it has been known that ParB protein of the F-plasmid and its homologues not only bind sequence-specifically to their cognate parS DNA sequence, ParB-binding spreads to nearby non-specific DNA areas, forming condensed partition protein-DNA complexes containing large numbers of ParB molecules. However, how such complexes are assembled remained a mystery. Recently, ParB proteins of this family have been found to bind CTP and have CTPase activity. By making use of magnetic tweezers to monitor DNA condensation, we found parS-containing DNA is condensed by ParB in CTP-dependent manner. The parS DNA sequence must be present in cis for the observed DNA condensation. Further details of the DNA condensation process and characterization of the dynamic properties of the complex are under investigation.